Novel Blood Biomarker of Alzheimer's disease Using Oral Glucose Tolerance

In this application, we propose to characterize a novel blood biomarker of Alzheimer's disease (AD). We previously demonstrated in a pilot study that the dynamic changes in plasma amyloid-beta (Aβ) levels after administration of an OGTT (hitherto referred to as “Aβ-OGTT?”) differentiates mild cognitive impairment (MCI) subjects from clinically normal (CN) subjects. In this proposal, we will demonstrate the following: (i) Aβ-OGTT? can also differentiate AD subjects from CN subjects; (ii) Aβ-OGTT? is associated with brain Aβ burden on Pittsburg Compound B-Positron Emission Tomography (PiB-PET); (iii) the mechanism of Aβ-OGTT? may be due to the role of Aβ-binding proteins (chaperones). In a cross-sectional study, we will administer OGTT to a group of individuals in each of the MCI, AD and CN groups. Plasma samples will be obtained at various time points after the administration of OGTT. Plasma samples will be quantified for Aβ 40, 42, and Aβ binding proteins. Aβ-OGTT? value will be calculated for all groups to determine if there are differences among the three groups. Aβ-OGTT? value will also be correlated with Aβ burden on PiB-PET in CN to determine if the plasma biomarker is reflective of the underlying pathology in a preclinical population. Finally, Aβ-OGTT? value will be correlated with Aβ binding protein levels. The results of this proposal will provide data regarding the potential utility of Aβ-OGTT? as a diagnostic biomarker of MCI and AD, as well as a biomarker of underlying disease state. It will also provide data on the potential relationship between plasma Aβ 40 and 42 levels and Aβ binding proteins, and whether there may be a more efficient clearance of Aβ in NC. In addition, the data from this proposal will enable us to gather sufficient data to design a longitudinal study to demonstrate the utility of Aβ-OGTT? in differentiating subjects, predict disease progression, and monitor therapeutic response.

Public health relevance
Project Narrative The goal of the proposed project is to develop a simple, non-invasive and easily accessible blood biomarker for Alzheimer's disease (AD). We will use oral glucose tolerance test (OGTT), which is already available in most community laboratories, to determine if the changes in the blood amyloid level after an OGTT can be helpful as a marker for AD. We will also determine if the changes in blood amyloid is reflective of the brain amyloid load, and to determine if we can understand how amyloid may be cleared from the blood.